Wake-sleep Circuitry in Neurodegenerative Dementias

Project Summary/Abstract
By age 75, individuals sleep about 1.5 hr. less per night, take longer to fall asleep, wake up more frequently at
night and are more likely to nap during the day than at age 25. Alzheimer’s disease, Parkinson’s disease/Lewy
body dementia, and fronto-temporal lobe dementia exacerbate these problems. We hypothesize that the
changes in wake-sleep and circadian behavior during aging are due to subclinical neurodegeneration
of wake-sleep and circadian circuitry as a continuous process during aging. This would be similar to
REM sleep behavior disorder, which often occurs 10-15 years before a diagnosable synucleinopathy. We
further hypothesize that different neurodegenerative disorders may affect different patterns of wake-
sleep and circadian cell groups and cause different behavioral changes. If this hypothesis is correct, it
may be possible to use specific sleep and circadian disturbances as biomarkers to identify early, preclinical
stages of these disorders. We propose here to test these hypotheses using two unique sets of subjects from
the Rush Memory and Aging cohorts, who have actigraphic recording of rest-activity behaviors. In the first set
of subjects, who have had actigraphy within one year of death and a brain autopsy, we will analyze the
actigraphy for sleep time, sleep fragmentation, and sleep efficiency during the night, nap time during the day,
and circadian activity phase and amplitude. We expect to find that cell loss will be associated with
deposition of pathological proteins in wake-sleep and circadian cell groups, and specific patterns of
wake-sleep and circadian behavioral deficits, even if there was no diagnosable neurodegenerative
disorder during life. In Aim 1, we will look at wake-promoting (orexin, tuberomammillary, A10, raphe,
pedunculopontine, parabrachial, and locus coeruleus), sleep promoting (ventrolateral preoptic, MCH), and
circadian (suprachiasmatic vasopressin and VIP neurons) cell groups for association between deposition of
neurodegenerative pathological protein deposits (beta-amyloid, phospho-tau, phospho-α-synuclein, phospho-
TDP-43) and reduced numbers of surviving neurons. In Aim 2, we will look for association of changes in sleep
time, efficiency, fragmentation, and napping, as well as changes in circadian amplitude or phase with numbers
of remaining neurons and deposition of neurodegenerative proteins in the same cell groups as Aim 1. In Aim
3, we will test a separate validation cohort of patients who had actigraphy 2 or more years prior to death and
clinical and pathological diagnosis at the time of death, to determine whether specific wake-sleep or circadian
deficits predict later neurodegenerative diagnoses. We hope to be able to identify patterns of wake-sleep
and circadian deficits during life using actigraphy, an inexpensive, non-invasive, and widely available
tool, that predict and act as biomarkers for subclinical presence of Alzheimer’s disease and other
neurodegenerative disorders, similar to the relationship of REM sleep behavior disorder and
synucleinopathies.

Public health relevance
Project Narrative Older people sleep less, have more fragmented sleep, and nap more during the day, but the cause of these changes is not known. However, we now know that neurodegenerative processes deposit the hallmark proteins for Alzheimer’s disease (Abeta and phospho-tau), Parkinson’s disease (phospho-α-synuclein) and fronto-temporal lobe dementia (phospho-TDP-43) in neurons in the brain for many years before the neurological disorder can be diagnosed. We will investigate whether the aging changes in sleep are due to the deposition of these pathological proteins in neurons in the wake-sleep and circadian circuitry in the brain and may serve as a biomarker for these disorders.